Utilizing the Chicken Embryo to Decode the Transcriptional Regulation of FOXE3

The discovery of precisely how transcription factors (TFs) function to regulate transcriptional programs during
development is of fundamental importance for understanding cellular identity and organogenesis. The
stereotypical architecture, anatomical simplicity and wealth of previous developmental information makes the
lens a particularly attractive tissue in which to tease out these discoveries. The advent of genome-wide
sequencing strategies to identify the epigenetic state of chromatin within specific cell types has made it possible
to identify cis-regulatory elements (CREs) that control gene expression within these cells. Using these strategies,
CREs that putatively regulate the lens TF gene, Foxe3 have been discovered in the mouse genome. The
expression of FOXE3 is largely restricted to the lens and homozygous loss of function mutations result in aphakia
and/or microphthalmia in all vertebrate species where these mutations have been identified, including humans.
As such, FOXE3 represents an attractive target to elucidate how TFs utilize cis-regulatory elements to achieve
tissue-specific gene expression. Furthermore, while studies in mice have identified Foxe3 CREs that contain
specific TF motifs and bind to specific TFs, to date the relative importance of any of these identified motifs in
regulating Foxe3 expression in vivo is lacking. The current proposal seeks to exploit the developmental
advantages of the chick lens to decode the cis-regulatory grammar that dictates FOXE3 expression in both the
chick and mouse lens. Building on recent information that uncovered genome wide chromatin accessibility and
the epigenetic active enhancer modification (H3K27ac) four putative FOXE3 CREs have been identified in the
chick genome. This proposal will annotate the mouse and chick FOXE3 CREs for the presence of known TF
binding motifs. The proposal seeks to employ recombinant retroviral vectors to functionally test the requirements
of these CREs to drive reporter gene expression in the chick lens. The proposal will utilize retroviral reporter
constructs to determine if specific TF motifs, discovered within essential FOXE3 CREs, are essential to drive
lens-specific expression. In addition, a lens-specific CRISPR based genome editing strategy will be developed
in the chick lens to screen candidate TFs for their requirement to drive the normal expression pattern of the
endogenous FOXE3 gene in developing chick lenses. The central hypothesis tested in this proposal is that
regions of non-coding open chromatin near the FOXE3 gene in both mice and chickens comprise promoter
and/or enhancer elements that interact with TFs sufficient to specifically drive gene expression to the developing
chick lens. The success of this proposal will not only directly test the role of specific CREs and TFs for their role
in regulating FOXE3 expression in vivo but it also promises to enhance the utility of the chick lens for screening
gene and enhancer function by developing CRISPR-based genome editing strategies.

Public health relevance
The proposed research is relevant to public health because many genetic diseases result from loss of transcriptional control of gene expression. The proposed research exploits the accessible embryonic chick lens to conduct a functional screen of cis-regulatory elements discovered by genome wide epigenetic analyses and to identify the transcription factors that interact with these elements to control FOXE3 expression. The proposed research is relevant to the NIH’s mission because normal expression of FOXE3 is required for human eye formation and this proposal provides direct tests of the transcription factors that control FOXE3 expression during chick lens development.